Biophysics Core Facility

The Biophysics Core Facility provides four main categories of services: (1) direct research support, including access to advanced instrumentation; (2) research collaborations and scientific consultations; (3) development and optimization of measurement methods; and (4) user training. Facility activity exceeded 2,700 instrument hours, reflecting sustained, high utilization across platforms. Users included principal investigators, staff scientists, postdoctoral fellows, and students from 59 NIH laboratories, spanning diverse programs and disciplines.